Cellular and Molecular Dynamics of Retinal Microglial in the Context of Photoreceptor Degeneration

SUMMARY
Many, if not most, forms of retinal degeneration involve ectopic accumulation of subretinal macrophages.
However, the contribution of bona fide microglia to this immune response and their independent role in disease
is poorly understood. It is now widely appreciated that macrophages in degenerating neuronal tissues are not
only comprised of microglia but may also include monocyte-derived macrophages. The former are endogenous
prenatal-derived cells maintained locally throughout life, whereas the latter represent transiently recruited
passengers in disease states. Hence, these two distinct lineages have nonredundant activities in the disease
process and should thereby be studied as distinct entities. However, distinguishing microglia is technically
challenging since standard techniques such as immunolabeling, conventional reporter mice, or myeloablation
bone marrow chimeras are insufficient to study these two populations. In fact, the only method to achieve such
separation is through recently established Cx3cr1-CreER microglia lineage tracing mice. Yet, few studies have
employed this approach, which has resulted in a knowledge gap in the field. As it is also now known that
microglia are essential in establishing and preserving neuronal activity in physiological conditions, determining
microglia-specific activities in retinal disease is now imperative. Using the lineage tracing approach and single-
cell RNA sequencing (scRNA-seq), our lab recently identified a novel population of cytoprotective retinal
microglia in photoreceptor degeneration models. We now wish to build upon these findings in our current
proposal by applying novel tools to unravel these cells mechanistically, as well as to determine the significance
of their cytoprotective program across etiologically distinct retinal degenerative diseases. We begin in Aim 1 by
leveraging our scRNA-seq dataset to inhibit microglial chemotaxis that will allow us to determine whether
cytoprotection is a subretinal-specific response. Aim 2 takes advantage of our scRNA-seq dataset as well for
targeted conditional and global knockouts to establish the molecular underpinnings of microglia-mediated
protection. Lastly, in Aim 3 we will apply loss- and gain-of-function studies to examine whether this
cytoprotective microglial program is operative in both primary photoreceptor degeneration and retinal pigment
epithelial pathology-related degeneration. In summary, our proposal is not only timely, but is also poised to
unravel the innerworkings of this novel microglial population across etiologically distinct retinal degeneration
models and perhaps help uncover novel therapeutic targets that can bolster their activities for vision
preservation in photoreceptor degeneration.

Public health relevance
PROJECT NARRATIVE Fifty percent of all blindness is due to retinal degenerative diseases, which are a group of conditions caused by damage to light sensing neurons of the eye. Involved in these diseases is a particular type of immune cell, called the myeloid cell. We now know that these cells are comprised of a variety of different subtypes, and we will elucidate their respective roles in disease that potentially may uncover new strategies for therapeutic purposes. ! ! !